The Ethics, Climate Change and Health Mentorship Project

ECCH ABSTRACT
According to a recent report from the United Nation’s Intergovernmental Panel on Climate Change,
Latin America is highly vulnerable to the effects of climate change (CC). Given the region’s
susceptibility to CC, its pre-existing inequalities, and limited resources, it is essential that possible
policies aiming to diminish the effects of CC in the region be enacted fairly. However, there is a total
lack of local academic and policy literature on the subject of CC from an ethics point of view. With
these major challenges in mind, the Ethics, Climate Change and Health (ECCH) Mentorship project
aligns with CC-related goals from the United Nations, World Health Organization (WHO), and US
National Institutes of Health to use mentor-trainee partnerships to train emerging scholars in analytical
reflection on how best to frame and tackle problems of health equity in the region. We selected four
such partnerships with scholars asking research questions related to ethics, CC and public health
policy in Argentina, Peru, Costa Rica, and Mexico on topics related to oncology, water security,
gerontology, and pediatrics. This one-year program will give trainees extensive contact with
established literature and scholars working in the field of CC, a unique 1-on-1 opportunity to hone their
English comprehension and communication skills and publish in Open Access journals, as well as
participation in international congresses. Individual and collective activities are scheduled so as to help
mentees achieve their training goals, in particular defending their Master’s thesis. Scientific and lay
press publication aided by published multi-lingual academics will allow mentees to achieve their
dissemination goals. In summary, it is hoped that rigorous training in ethics applied to local problems,
with direct implications for policy and publishable results for leading journals, will strengthen the
region’s resilience to CC. Finally, the project will also promote the bioethics and CC training
capabilities of the FLACSO Program of Bioethics (parent award), a member of the Global Network of
WHO Collaborating Centers for Bioethics.

Public health relevance
ECCH NARRATIVE The Ethics, Climate Change and Health Mentorship Project gathers a team of mentors and Fogarty trainees from LMICS in Latin America to conduct research on urgent issues of health justice resulting from climate change. These include the appropriate public policy response to adverse effects of climate change in different areas including cancer treatment, vulnerable elderly and pediatric populations, and management of scarce resources such as water. To this end, we will train mentees in argumentative critical thinking and writing skills, apply this skillset to the ethical dilemmas that underpin local decision making in clinical and public health due to climate change, and disseminate this relevant local research internationally.